Pathogenesis of Monoclonal Gammopathy Bone Disease

DESCRIPTION (provided by applicant): Skeletal fractures due to low bone mass are projected to increase markedly as the United States population ages. Identifying and providing care to individuals at greatest risk for fracture is therefore of paramount importance. While the incidence of bone loss and fractures increases with aging, so too does the risk for developing a monoclonal gammopathy, a collection of plasma cell disorders which includes monoclonal gammopathy of undetermined significance (MGUS), smoldering multiple myeloma (SMM), and multiple myeloma (MM). MGUS is the most common monoclonal gammopathy, affecting roughly 3.2% of adults aged 50 and older (correlating to nearly 3 million current US residents). While osteolytic lesions and fractures are a well-recognized complication of MM, far less is known about the skeletal health of subjects with MGUS and SMM. Recent data demonstrate that subjects with MGUS have an increased incidence of fractures. Our preliminary data demonstrate that MGUS subjects have significantly diminished bone mass, altered bone microstructure, and increased serum levels of factors [Dickkopf1 and macrophage inflammatory protein 1-1)] known to correlate with osteolytic lesions in MM. The objectives of this application are to characterize the bone changes that occur in humans with monoclonal gammopathies at both a skeletal level (through both epidemiologic and imaging-based approaches) and a cellular level (by determining if alterations in osteoblast (OB) and osteoclast (OC) activity across the entire spectrum of monoclonal gammopathies result from common mechanisms). Aim 1 seeks to examine bone microstructure (using high-resolution peripheral quantitative computed tomography) in patients with SMM and MM, and to determine if SMM is associated with an increased fracture incidence. Osteolytic lesions in MM bone disease result from both inhibition of OB progenitor cell differentiation and enhancement of OC lineage cell differentiation. Aim 2 seeks to determine the signaling pathways within OB and OC progenitor cells which are altered in MM, and whether these same alterations also occur in OB and OC lineage cells in MGUS and SMM. This will be determined by isolating highly-enriched OB and OC progenitor cell populations from the bone marrow of subjects with MGUS, SMM, or MM and matched controls, and determining changes in gene expression along both focused and potentially novel pathways. Aim 3 will focus on whether in vitro, OB and OC progenitor cell differentiation and activity can be modulated by selective inhibition of the signaling pathways identified in Aim 2 to prevent OB inhibition or OC stimulation induced by culture of OB and OC progenitor cells with BM plasma from MGUS, SMM, or MM subjects.

Public health relevance
Project Narrative A more thorough understanding of the mechanisms underlying the increased fracture risk that occurs in patients with monoclonal gammopathies (MGUS, SMM, and MM) is fundamentally important if we are to provide improved care for the approximately 3 million Americans affected by this class of related plasma cell disorders. The work described in this application offers a unique opportunity to study bone progenitor cells within the bone marrow microenvironment, the site to which plasma cells localize and grow, leading to bone loss and increased fracture risk. The proposed studies will provide both a skeletal phenotypic and molecular assessment of monoclonal gammopathy bone disease in humans, and will allow us to determine if common mechanisms of osteoblast suppression and osteoclast stimulation occur in pre-malignant (MGUS and SMM) as well as malignant (MM) monoclonal gammopathies. __SpecificAimsTextDelimiter__ II.4.A. Specific Aims Skeletal fractures are projected to increase markedly with the aging United States (US) population and represent a growing health problem for the nation. Identifying and providing appropriate care to those individuals at greatest risk is therefore of paramount importance. While the incidence of bone loss and fractures increases with aging, so too does the risk for developing a monoclonal gammopathy (MG), a spectrum of related disorders that includes monoclonal gammopathy of undetermined significance (MGUS), smoldering multiple myeloma (SMM), and multiple myeloma (MM). MGUS is the most common MG; it affects roughly 3.2% of adults aged 50 and older, and has a 1% annual risk of progression to multiple myeloma (MM) [4]. Smoldering multiple myeloma (SMM) is the intermediate stage along the MGUS-MM continuum, but carries an approximately 10% yearly risk of transformation to MM. MM is a severely debilitating, incurable, and uniformly fatal neoplastic disease of B cell origin; median survival is 3-4 years from diagnosis. Among all malignancies, MM has the highest incidence of skeletal involvement. Osteolytic lesions affect nearly 90% of subjects [7] and are the result of both increased osteoclast (OC) and suppressed osteoblast (OB) activity. Although MGUS subjects outnumber those with MM nearly 20 to 1 [8], far less is known about bone health in MGUS; further, no studies have examined skeletal health in SMM. Although fracture risk is substantially increased in MGUS [9], it is uncertain whether MGUS is associated with reduced areal bone mineral density (aBMD). Our preliminary data using high-resolution peripheral quantitative computed tomography (HRpQCT) shows that MGUS subjects have markedly diminished bone mass and altered bone microstructure. Further, we find MGUS is associated with increased serum levels of Dickkopf 1 (DKK1) and macrophage inflammatory protein 1-α (MIP-1α), factors known to correlate with OB suppression (DKK1) and OC activation (MIP-1α) in MM bone disease. As such, our preliminary data suggest that mechanisms underlying bone loss in MM may also extend to the pre-malignant conditions MGUS and SMM. Our current deficit in understanding MG-associated bone loss is an important problem because it limits our ability to reduce the fracture risk in these patients. Our long-term goal is to understand how OB and OC activity can be modified to prevent malignancy- associated bone loss. The objectives of this application are to characterize the bone changes that occur in humans with MGs at both a skeletal and a cellular level. We hypothesize that: 1) decreased bone mass, altered bone microstructure, and increased fracture incidence occur in all MGs (Specific Aim #1); 2) signaling mechanisms common to all MGs lead to inhibition of OB progenitor cell differentiation and enhancement of OC progenitor cell differentiation (Specific Aim #2); and 3) in vitro, OB progenitor cell differentiation can be inhibited, and OC progenitor cell differentiation stimulated, by incubation with BM plasma from MG patients; further, selective modulation of the signaling pathways identified in Aim 2 can prevent BM plasma-induced changes in OB and OC progenitor cell function (Specific Aim #3). To address our hypotheses, we have developed a multi-pronged translational approach. First, we have initiated studies using the novel technique of HRpQCT (which essentially provides an "in vivo bone biopsy") to assess skeletal microstructure in MGUS subjects. Second, we have developed methods to isolate highly enriched hematopoietic lineage negative (lin-)/alkaline phosphatase positive (AP+) OB lineage cells, and highly enriched CD14+/calcitonin receptor positive (CTR+) OC lineage cells directly from human BM aspirates. Third, we have developed cell culture methods which will allow us to examine in vitro how modulation of bone progenitor cell signal transduction pathways affects progenitor cell ability to respond to osteoblastogenic and osteoclastogenic signals. Thus, this project has three Specific Aims: Specific Aim 1: Determine if SMM is associated with an increased incidence of fractures and if SMM and MM subjects have alterations in bone microstructure. a. We will determine whether fracture incidence is increased in subjects with SMM compared to subjects without disease, and compare this to incidences we have previously determined for MGUS and MM. b. We will test if SMM and MM subjects have altered bone microstructure that is not evident by standard aBMD imaging by dual energy x-ray absorptiometry (DXA). c. We will determine if skeletal microstructural alterations in SMM and MM correlate with tumor burden (serum paraprotein levels and % BM plasma cells), or risk for SMM progression to MM. Specific Aim 2: Identify changes in gene expression that occur in OB and OC lineage cells in vivo from MG patients. a. We will test if suppression of components of the Wnt and bone morphogenetic protein (BMP) signaling pathways occurs in humans with MM. b. We will determine whether OC hyperactivation in osteolytic MM is associated with the simultaneous activation of multiple osteoclastogenic signaling pathways (RANKL, c-Fms, TNF-α, IL-1, and MIP-1α). c. We will determine using microarray analyses and quantitative real-time PCR (qPCR) if activation or inhibition of novel pathways occurs in OB and OC lineage cells of subjects with MM. d. We will determine by qPCR if these pre-specified and novel pathways are affected in MGUS and SMM. Specific Aim 3: Determine if modulation of known and novel signaling pathways prevents OB inhibition and OC activation in vitro. a. We will assess the differentiation and activation of OB and OC progenitor cells cultured with BM plasma from MGUS, SMM, or MM subjects in the absence or presence of antagonists (in cases where the pathway is aberrantly activated) or agonists (where the pathway is aberrantly suppressed) to pre-specified signaling pathways. b. We will modulate the novel pathways identified to determine if OB and OC lineage cell differentiation and activation are affected when cultured with BM plasma from MGUS, SMM and MM subjects.